Genetic rescue of a developmental hearing loss-induced spectral processing deficit

PROJECT SUMMARY
Even transient developmental hearing loss (HL) can cause lasting deficits to auditory perception, affecting
speech and language acquisition and subsequent educational attainment for many children. Although research
suggests that developmental HL can impair temporal processing (e.g., amplitude modulation processing), there
is evidence that impairments to the perception of the spectral content are closely correlated with speech
comprehension. Furthermore, there is evidence that these deficits are due, in part, to a long-lasting reduction in
the strength of inhibitory synapses in auditory cortex (AC). Therefore, the goals of this proposal are to assess
the impact of developmental HL on a spectral modulation (SM) detection task in gerbils and to identify a causal
relationship between perceptual deficits and reductions in GABAB receptor-mediated inhibition in AC. The core
hypothesis of this proposal is that developmental HL will cause a reduction in the function of postsynaptic
GABAB receptors, thereby impairing AC encoding of spectrally modulated stimuli and leading to SM detection
deficits. Two aims test predictions emerging from this hypothesis: Aim 1A will determine the influence of
developmental hearing loss on detection of SM stimuli. Gerbils will be reared with bilateral earplugs from P11-
23, a time when AC inhibition is particularly vulnerable. Twelve days after earplug removal, animals will be tested
on a SM detection task. SM thresholds will be obtained across 10 days so that perceptual learning and
asymptotic performance can be compared between control and HL-reared animals. Aim 1B will determine
whether developmental HL impairs AC neuron encoding of SM stimuli using an awake-behaving preparation.
AC will be implanted with an electrode array and recordings will be acquired during SM task performance. Neural
sensitivity to a range of modulation depths will be measured between normal hearing and HL animals. Aim 2 will
test the prediction that reduced functional GABAB receptors in AC contribute to impaired perception of SM after
developmental HL. Using a novel AAV vector to express a gerbil-specific GABAB receptor subunit (Gabrb1b)
obtained from the recently sequenced gerbil genome in AC after developmental HL. The AAV-Gabrb1b vector
will be injected bilaterally into AC after earplug removal. Behavioral testing will then be performed to determine
whether normal SM detection thresholds are restored. Together, these aims will advance our understanding of
the neural mechanisms underlying perceptual deficits attending developmental HL and identify a path towards
developing the first pharmaceutical treatments for its lasting consequences.

Public health relevance
PROJECT NARRATIVE Up to 80% of children suffer at least one bout of impaired hearing during a time when the brain is especially vulnerable to deprivation, often causing lasting deficits in speech comprehension which are correlated with impaired perception of changes in the spectral content of sounds. This proposal seeks to 1) establish an animal model to assess perception of spectral modulation, 2) assess the impact of developmental hearing loss on perception and neural coding of spectral modulation and 3) test a novel gene therapy approach to rescue these deficits. This work will address an important lack of understanding of behavioral deficits following hearing loss and help direct future research towards therapeutic interventions.